The Science of COVID-19 Vaccines

This request for supplemental funds will allow us to expand and refine instructional materials addressing the science of coronavirus and the role that vaccines can play in eradicating this virus. Instructional materials that will be created with these supplemental funds include (i) a video that specifically addresses the science behind current vaccine development efforts and their testing in clinical trials, (ii) physical models of coronavirus,? enhanced with augmented reality technology (iii) new molecular landscape posters (featuring the art of David Goodsell) that present engaging images of a coronavirus within a respiratory droplet and the structure of an mRNA vaccine and (iv) a condensation of the AeroNab story into a video targeted to the general public. The materials created in tis project will be made available to underserved minority students in both urban and rural settings.

Public health relevance
This request for supplementary funds is related to our current SEPA grant (R25GM129218) entitled The Science and Ethics of Genome Editing. The major goals of this program are to: (i) create innovative, hands-on instructional tools that will engage students in this topic and (ii) to develop a professional development experience for high school biology teachers that will update their knowledge about this subject and introduce them to these new instructional materials. Research has shown that teacher effectiveness is closely correlated with improved student performance in the classroom. Our project consists of a professional development experience designed to increase both the content knowledge of teachers and to sharpen their pedagogical skills. The content focus of the project addresses the integration of basic concepts of genetics with the molecular genetics of today, and the new science of genome engineering that will shape tomorrow. The project is also training teachers in a pedagogy that values questions over answers and encourages students to develop their critical thinking skills. The project is aligned with the goals of the CoSTEM Strategic Plan – to train additional K‐12 STEM teachers and to build a more diverse biomedical workforce. Another hallmark of our current and past SEPA projects has been the partnerships that we build with research labs actively involved in exploring the biology we are teaching. For example, in our current project, we are working closely with Jennifer Doudna’s group at UC Berkeley to tell the story of CRISPR and its potential use in editing the human genome. These same hallmarks will be reflected in the supplementary project outlined below, focused on the development of materials to address the topic of a coronavirus vaccine and vaccine hesitancy. The coronavirus outbreak in early 2020 resulted in a major disruption to our SEPA project. The two workshops that were scheduled for the summer of 2020 were cancelled, forcing us to resort to online technology to remain in touch with our teachers during these difficult and chaotic times. At the same, we recognized that the pandemic provided us the opportunity to support our teachers with the development of new digital, online resources they could use to engage their students in an exploration of the science of coronavirus. As we pivoted our efforts to the topic of coronavirus, we quickly developed a series of online resources. Those resources included: 1. A COVID-19 Video Series,…for students. https://www.3dmoleculardesigns.com/The-Science-of-Coronaviruses.htm One of the first resources we developed in response to the pandemic was a series of videos addressing the science of coronavirus. These short videos (18 total videos, 2 – 5 minutes each) were targeted to students. The series covered a range of topics from What is a virus?, to the Structure of coronavirus and How do vaccines protect us from coronavirus? The series ends with an assertion that Science is the answer to this current pandemic, and that lessons learned as the scientific community pivoted to deal with COVID19 makes future pandemics less likely. Our goal in creating these videos was to provide teachers with an online resource they could use in a remote learning environment to engage their students in this topic. We tried to emphasize not only the science of coronavirus, but also the way in which prior investment in basic research has prepared the scientific community to pivot rapidly and effectively to provide vaccines and antivirals agents to combat this virus. This video series has been viewed by over 4,000 students and teachers to date. We have not yet had time to survey teachers with regard to their perceived usefulness of the series, but we anticipate that this resource will continue to be used in post-pandemic years as teachers continue to look for a current phenomena that will capture the interest of their students. 2. A Series of Coronavirus Models,… with an antibody binding to the spike protein. A series of physical models of a coronavirus have been developed featuring the virus membrane, the spike proteins and the RNA genome. The model is magnet-docked onto an ACE-2 receptor protein embedded in a patch of cell membrane. A yellow antibody protein is magnet-docked onto a spike protein. A paper-based coronavirus modeling exercise is included in this COVID-19 video series. 3. An Antibody MAPS Module,... featuring the AeroNab Story of COVID-19 research. https://cbm.msoe.edu/mapsTeams/antibodies.php A new Antibody Module was added to our MAPS student modeling web site as a way to introduce students to the role of vaccine-induced antibodies in preventing COVID-19 infection. This module also includes the story of a diverse group of UCSD researchers who pivoted from their normal research projects to create a single-domain nanobody with the potential to block CoV-2 infection. 4. The 2021 Webinar Series,... allowing teachers to continue their professional development in a virtual environment. https://www.3dmoleculardesigns.com/Webinars4.htm We have launched a 12-session series of webinars for teachers that allow them to continue to engage in professional development activities during this time when travel to state, regional or national science education conferences is not possible. The first topic addressed in the webinar series was the Science of Coronavirus. One hundred and thirty teachers participated in this initial webinar. Although the materials related to COVID-19 described above represent a good start on both physical and virtual tools that can be used to engage students and their parents in an exploration of the science of coronavirus and the role of vaccines in protecting us from infection, they fall short in several ways: • Vaccines are only mentioned briefly in the video series, with no reference to the history of vaccines that have successfully suppressed virus outbreaks in the past. • We have not addressed novel approaches to vaccine development,… such a mRNA vaccines. • We have told only one half of the vaccine story,… describing the role of antibodies in preventing infection. We need to add the second part of that story to our vaccine materials, i.e. the role of T-cells in suppressing an infection after it has been established. • Many of the materials we have developed in the past year are simple, static physical models or illustrations that are not immediately engaging to students. We now see a way to enhance the impact of these models with the use of Augmented Reality Technology. The supplementary funds requested here will allow us to continue to refine and add to these COVID-19 related resources with a specific focus on vaccines and vaccine hesitancy. Specific refinements and additions that will be supported with these supplementary funds include: 1. A new video entitled Vaccs to the Future,… addressing the science of vaccines and their importance in controlling a viral pandemic. This expanded video will enhance our current cursory treatment of this topic by adding materials related to (i) the history of past vaccine campaigns in controlling a long list of diseases such as small pox, measles, and polio, (ii) the recent development of new vaccine technologies including mRNA vaccines and multi-valent vaccines composed of viral proteins embedded in spontaneously assembling protein shells, and (iii) the role of cellular immunity (T-cells) in fighting a viral infection once it is established. This video will be used in future webinars for teachers, virtual presentations at national meetings of science educators (NSTA, NABT and State meetings of science teachers), and in future teacher training workshops in the CBM. In addressing the topic of new vaccine development technologies, we will be relying on our long relationship with the David Baker group at the Institute for Protein Design at the University of Washington. 2. Physical models of coronavirus,… enhanced with Augmented Reality technology. We have already designed several large physical models of a coronavirus for use in classrooms. We have also begun to create small, simplified versions of these models for individual use by students or the public. To keep the cost of these mini-models low, it is necessary to eliminate multiple colors that could otherwise highlight specific components of the virus – like the spike protein and the RNA genome. But we now plan to augment these simple monotone physical models with colorful virtual images that are overlaid onto the model when viewed through a phone. The augmented reality technology to achieve this enhancement is now being developed in a Phase I SBIR project recently awarded to our sister organization 3D Molecular Designs. (The supplemental funds requested here will not be used to fund the development of this technology, only to apply that technology to these vaccine-related materials.) For example, when viewed through a phone, the spike proteins will be overlaid with red-colored spike proteins. These virtually added red spike proteins will track with the physical model as it is turned over in the hand of the user. In another enhancement, a virtual image of the virus will be overlaid onto the model that shows a cut-away of the virus shell, revealing the RNA genome. Our ultimate goal is to trigger an audio file that will explain the new feature that has been added to physical model. 3. New molecular landscape posters featuring a coronaviruses and an mRNA vaccine. We plan to use two new Goodsell Landscapes that illustrate (i) a coronavirus contained within a respiratory droplet and (ii) an mRNA vaccine encolsed in a lipid vesicle. These images, created by our colleague David Goodsell, will be converted into posters with appropriate captions that explain the features represented in the landscape. Once again, we plan to enhance the learning value of these posters with augmented reality technology. We have recently learned how to track the fingers of the user’s hand with this technology. The next step is to indentify the fiducial markers in the poster that when touched by a finger launches either a pop-up widow that identifies the protein that has been touched and/or an An mRNA vaccine audio file that provides more A coronavirus,… in a information about the component respiratory droplet that has been touched. 4. Re-packaging of the AeroNab story for a more general audience. In the past year we have created a new Antibody Module for our student-centered MAPS program. The online resources that support this modeling project are divided between twelve short videos that present different aspects of antibody structure and the role of vaccines in stimulating the body to produce these proteins (https://cbm.msoe.edu/mapsTeams/antibodies.php ). As the final component of these materials, we suggest that students explore the AeroNab story, and model the single-domain antibody that was the result of this work. While these materials work well to lead students through this modeling project over a several- month period of time, they are not useful in delivering a focused massage to the public about the science of coronavirus. Therefore, we plan to condense these materials that explain the structure of an antibody,… and how antibodies inactivate coronavirus spike proteins,… and how an engineered single-domain antibody (i.e., a nanobody) can be used to prevent coronavirus infection. While this story is not specifically about a vaccine, we will use this condensed story to engage the public in an important message about the process of science and how the investment in basic research is leading to innovative solutions to the current pandemic. As students, parents and the general public become more informed about the role of science in solving the problem posed by CoV-2, they will also become more accepting of the vaccine that this science has delivered. Our current SEPA project benefits from the input of a Teacher Advisory Board (TAB) composed of educators who are experienced users of the CBM’s instructional materials. We will call upon a subset of these teachers to contribute to the expansion of our COVID-19 vaccine materials. The TAB will contribute to this project is two ways; (i) These teachers will provide a classroom perspective regarding how, and to what level of detail, the broad topics of viruses, vaccines and the immune system are commonly taught in a range of high school courses. We will also involve them in a virtual brainstorming session regarding our plans to expand these materials. (ii) Once these additions are made to our instructional materials, these teachers will provide the project with an initial evaluation of the impact of the materials on their students learning. Our past experience in working with TABs suggest that these teachers will contribute valuable feedback that will lead to an iterative improvement of our initial materials. Underserved students and community who may be vaccine hesitant. A stated goal of these supplements is to create innovative instructional materials to increase vaccine confidence and encourage vaccine acceptance of the public, especially among populations with a high level of vaccine hesitancy. To address this goal, we plan to work with two other partners who have established relationships with students and parents who are currently thought to be vaccine hesitant: 1. We plan to work with Maurice Godfrey whose SEPA project is specifically focused on students of tribal schools in Nebraska and South Dakota. We will provide the vaccine materials that result from these supplemental funds to Dr. Godfrey’s program and participate via virtual technology in working with these students as they explore this topic. 2. We have recently begun working with Sanjib Bhattacharya of the Milwaukee Health Department (MHD) to provide physical models of the coronavirus to use in their outreach programs with three high schools in the urban Milwaukee Public Schools. MHD currently plans to give a small coronavirus model to each student in this outreach program. We anticipate that the augmented reality technology described above will be useful in adding significantly to the educational value of these small, simple physical models. Specifically, we envision a student holding the small virus in one hand,… and then viewing that model through their phone—as virtual images of multiple antibodies appear and bind to the spike proteins on the surface of the virus. The overall goal of this project is to educate the general public regarding coronavirus vaccines and the importance of being vaccinated. The Project Logic Model that guides this effort is based on two related thoughts; (i) the students of today are the parents of tomorrow. Therefore, by educating students as to the value of vaccines, we will be preparing the citizenry of tomorrow to appreciate the value of vaccines. (ii) students can play a role in disseminating this appreciation of vaccines to their parents. Our hope is that students will talk with their parents about what they are learning,… using simple hands-on models to explain how vaccines work. (iii) teachers are the key short-term component in this effort to impact the public’s understanding of the importance of vaccines. Short-Term Goals: Use resources of the CBM,… including its established community of 300-plus SEPA teachers,... to create instructional materials addressing coronavirus vaccines. Intermediate-Term Goals: Teachers will use the project’s instructional materials to introduce their students to the science of vaccines. Long-Term Goals: In addition to working with students in their own classrooms, many of our experienced SEPA teachers are beginning to host their own local training sessions for other teachers in neighboring schools. These local workshops will further disseminate this project’s materials to other teachers, who will in turn use these materials with their students, resulting in a broad dissemination of these materials. Funds are budgeted here to cover the expenses of our TAB members in hosting local teacher training workshops. These local, teacher-led workshops will more broadly disseminate the materials created in this project.